An AI Enabled Training Tool for Complex Surgical Suturing Skills

Abstract
Gravitate AI proposes to develop a novel Artificial Intelligence (AI)-led training tool for the assessment and
development of suturing skills, designed to provide objective, standardized, and immediate feedback for surgical
trainees in a convenient and self-sufficient manner outside of the operating room. Suturing is a vital surgical
technique that requires skilled precision, dexterity, and efficiency and constitutes a major component of technical
proficiency for both open and minimally invasive surgeries. Mastering the art of suturing technique is pivotal
across numerous surgical specialties involving complex suturing of vital structures often at difficult angles and
various depths in order to produce the best outcomes for patients; however, surgical trainees are limited in both
time and opportunities to gain technical practice and receive feedback on their performance. Simulation models
are one avenue by which to address the increased demands on modern surgical education by shifting more
training to controlled settings. However, despite increasing efforts to develop suitable tools, there remains a
significant gap in simulator technologies for complex suturing techniques, especially at depth, and even fewer
existing technologies that can provide rapid, quantitative feedback. There is a great need for such tools to
empower training surgeons in the operating room and produce the best outcomes for patients.
The proposed work will build on Gravitate AI’s previously developed prototype, which consists of proprietary
hardware and algorithms that analyze both static images of sutured material and dynamic recorded video footage
of surgeons in action. The algorithms detect key features of suturing technique such as speed and economy of
motion, while also evaluating suturing accuracy and uniformity via image segmentation based on predefined
criteria determined by experienced surgeons. If successful, the project will result in an improved and validated
tool which innovates significantly over traditional assessments of technical skill, mostly consisting of subjective
feedback from attending surgeons. Our AI-powered tool offers a more standardized, yet personalized approach
that enables comprehensive analysis and feedback based on nuanced and evidence-based metrics. The project
has 2 primary Aims: 1) develop an improved AI algorithm for processing both live-feed and recorded videos of
practicing surgical trainees, and 2) demonstrate proof-of-concept for consistent practice with the tool to increase
key performance metrics—namely suturing uniformity, time to completion, and motion economy—in
unexperienced resident surgical trainees over a 3-month period. This work will thereby support the advancement
of a transformative AI training tool that will greatly help trainees effectively practice and perfect critical suturing
skills, as well as equip supervisors with a reliable method to objectively track their trainees’ skill level and
progress, which will result in superior outcomes for patients undergoing surgical operations. Results will directly
inform a Phase II follow-on effort, involving longitudinal efficacy studies of surgical trainees using ex vivo models,
as well as R&D expansions to other surgical contexts.

Public health relevance
Abstract Gravitate AI is developing a novel Artificial Intelligence (AI)-led training tool for surgical trainees, designed to assess their suturing technique through video recordings and provide constructive, concrete metrics of performance. The technology will serve an unmet need in the surgical landscape by providing trainees with a rapid, easy-to-use, and low-cost method of developing proficiency in critical suturing techniques outside of the operating room and by providing feedback in a convenient and self-sufficient manner. Gravitate AI’s training tool will significantly improve surgical performance and increase confidence of trainees, creating immense value for practicing surgeons and leading to better patient outcomes during surgery.